Core D: Data Management and Analysis Core

SUMMARY – CORE D
Core D requires extensive data processing and management capabilities to generate high-quality, integrated,
harmonized, and analysis-ready data, and also the ability to implement statistical methods and analysis tools.
Core D aims to provide a platform for data management and sharing for all ACAD cores and projects, as well
as facilitate internal and external scientific collaborations using the ACAD data. Core D specifically will 1)
d
evelop and maintain a centralized data management system for clinical data, lifestyle surveys, sample
collection information, and prescreening and/or non-clinical data collection, 2) apply quality control protocols
across all data and prepare analysis ready datasets for the Projects, 3) facilitate data access and sharing within
and outside the ACAD community by providing infrastructure and expertise in data management, sharing, and
analysis across all ACAD cores and projects, and 4) integrate external resources and provide analytic
consultations by incorporating external data resources to expedite innovative scientific projects by ACAD
investigators using ethnically diverse datasets. The Core D leadership and personnel will closely interact with
the recruitment sites of the Administrative, B-HEARD (Outreach), Clinical, Biosample, and Training Cores
for implementation of data collection protocols, data and sample analysis flow, and data sharing and
management.